Psychological and Epigenetic Predictors of Obesity & Metabolic Disease

PROJECT SUMMARY/ABSTRACT
This proposal seeks to investigate the predictive ability of psychological and epigenetic markers for success of
lifestyle interventions in patients with obesity. Obesity is a growing public health crisis, and in the coming
decades it is expected that 50% of Americans will have obesity. Current treatment practice typically begins with
lifestyle interventions, followed by the addition of pharmacologic or surgical treatment if lifestyle interventions
fail. However, many individuals fail lifestyle interventions, their obesity continues to progress, and they
develop additional obesity-related comorbidities such as Type II Diabetes. While patients may be placed on
anti-obesity medications following the failure of lifestyle interventions, studies have demonstrated that
increased duration of obesity increases the risks of obesity-related morbidity.
Both behavioral and biological factors contribute to the development, maintenance, and progression of obesity
and obesity-related diseases. Stress has been found to increase the risk of obesity, and psychological resilience
factors such as self-control affect feeding behavior as well as biological markers such as insulin resistance.
Research has also suggested epigenetic modifications as a potential biological mechanism through which
environmental factors may affect obesity and may contribute to comorbidities such as Type II Diabetes.
Methylation of specific CpG sites has been associated with obesity and there are indications specific
methylation patterns may be predictive of worsening obesity and/or the development of insulin resistance. The
objective of this proposal is to utilize psychological and epigenetic data to predict obesity, insulin resistance,
and HgbA1C in response to lifestyle interventions. Findings from this study may be directly applicable to
clinical practice. By identifying patients with psychological (Aim #1) or epigenetic (Aim #2) factors at baseline
that predict likely failure of lifestyle interventions, these patients could be directed toward pharmacologic or
other treatment more likely to help. Specific epigenetic changes following lifestyle interventions (Aim #3) could
also predict long-term success or failure and may guide whether escalation of treatment is needed. Ultimately,
we hope this study will lead to development of a multi-modal predictor of treatment outcomes (Exploratory
Aim) which can provide individualized, prospective guidance of treatment decisions.
This proposal will integrate state-of-the-art facilities at Yale with a highly interdisciplinary team and an
established, well-funded ongoing study. The applicant has assembled a team of expert mentors in clinical trials
treating obesity, the neurobiology of obesity, stress and resilience, epigenetics, and advanced computational
methods. Formal didactics, scientific workshops, and national meetings will support the applicant’s training
and help leverage his robust clinical foundation with fellowship training in psychiatric care for the medically ill.
The vital support from this K23 award will allow for the applicant’s development into a leading independent
researcher applying psychiatric and computational methods to improving outcomes in patients with obesity.

Public health relevance
PROJECT NARRATIVE This proposal aims to determine how psychological or biological factors predict outcomes of people with obesity following lifestyle interventions. The results from this study will provide evidence as to how stress, resilience, and epigenetic data can predict the efficacy of lifestyle interventions at reducing weight and preventing the development of insulin resistance and type II diabetes. By improving our understanding of what treatments will succeed for a given patient, this proposal will accelerate the development of precise, individualized treatment for people with obesity, allowing individuals to more quickly obtain the treatment that will work best for them.